Forecasting Trachoma Control - Diversity Supplement

PROJECT SUMMARY/ABSTRACT
Annual mass azithromycin distribution dramatically reduces the prevalence strains of Chlamydia trachomatis
that lead to blindness. Current World Health Organization guidelines indicate that annual mass azithromycin
distribution should be continued until district-level prevalence of the clinical sign of trachoma, trachomatous
inflammation-follicular (TF), drops below 5%. However, TF does not correlate well with true prevalence and
there is no gold standard to detect this. Here, we propose that a Hidden Markov Model 1) will identify the true
prevalence in hypo-endemic areas that can be used as a signal that the mass azithromycin protocol was
successful and an indicator to stop antibiotics and 2) identify hyperendemic areas that the protocol has not
been successful to change the treatment regimen. We anticipate that results will provide evidence to support
altering the modification of current interventions for trachoma.

Public health relevance
PROJECT NARRATIVE Our project implements a clustered latent class analysis (LCA) approach using baseline data from the Trachoma Elimination Follow-up (TEF) study to evaluate diagnostic indicators including DNA-PCR assays. Through Bayesian analysis and LCA, we can leverage the sensitivity and specificity derived from trachoma diagnostic tests to compute disease prevalence accurately. This advanced statistical approach will provide data-driven insights to optimize trachoma control strategies and accelerate eradication efforts in vulnerable populations.